SUBCLASS AND CLONAL DIVERSITY OF ANTIBODIES TO POLYSACCHARIDE ANTIGENS

This study assesses the maturation of the serum antibody response of children to polysaccharide antigens. Serial serum samples from children of various ages will be assayed for antipolysaccharide antibody with respect to IgG subclass distribution and clonal diversity. Throat cultures are obtained to evaluate antigen (pneumococcus, group A beta strep) exposure.